Targeting the Cancer Stem Cell Population in Head and Neck Squamous Cell Carcinoma

Abstract
Head and neck squamous cell carcinoma (HNSCC) is a pervasive and dangerous disease with a 5-year
survival rate of only 40-50%, demonstrating the need for improved therapeutics. The cancer stem cell (CSC)
population in HNSCC has become an emerging area of study given its impact on treatment failure,
metastasis, and its detrimental impact on patient survival. Therefore, the HNSCC CSC population is an
essential target for new treatments. We revealed that the P53-related transcription factor ΔNp63α is required
for HNSCC CSC self-renewal, invasion, and migration. Preliminary data also reveals a strong transcriptional
impact of ΔNp63α on ELK3, uniquely in CSCs. ELK3 is an ETS-domain containing transcription factor
involved in the hypoxia response. ELK3 has been observed to play a role in invasion, migration, and
retention of stemness in certain cancer types; here, I propose that ΔNp63α-driven ELK3 regulates these
same properties in the HNSCC CSC population. In addition to uncovering this novel CSC signaling axis, I
have also discovered KDM2A as an upstream regulator of the pathway. KDM2A is a lysine demethylase that
primarily functions on histone H3K36me2 marks. Since this methylation mark is associated with an active
chromatin conformation, KDM2A is typically studied as a repressor of target genes. I discovered HNSCC
cells to be dependent on KDM2A for survival through a CRISPR screen targeting over 200 chromatin
modulating proteins. In addition to this, I found that KDM2A regulates the expression of both ΔNp63α and
ELK3, as well as the HNSCC CSC phenotype these factors invoke. This novel finding opens the door to
potential therapeutic intervention on a critical axis that maintains a poor differentiation state within the cancer.
Thus, I will perform genetic rescues, ChIP-seq, and single cell RNA-seq experiments to better understand
the mechanism of action behind KDM2A-ΔNp63α-ELK3 signaling. Furthermore, I will move my research in
vivo to more accurately assess the practicality of targeting this pathway in tumors. This is unique work that
will give me the opportunity to develop new technical skills like ChIP-seq, scRNA-seq, and tumor xenograft
studies in mice. I will also continue my growth as a scientist through grant writing, attending Cold Spring
Harbor Laboratory (CSHL) courses, student mentoring, reviewing manuscripts, and presenting my work in a
number of formats at both CSHL and Stony Brook University, and also at outside scientific venues. Overall,
this training opportunity will greatly enrich my graduate experience and prepare me for becoming a
successful postdoc, thereby fostering my transition to independence.

Public health relevance
Title: Targeting the Cancer Stem Cell Population in Head and Neck Squamous Cell Carcinoma Project Narrative Cancers of the head and neck (HNSCCs) are aggressive malignancies for which therapy initially works, only for the tumor to later re-grow and move to distant tissues of the body, yielding poor patient outcome. Cancer stem cells (CSCs), a rare population of rogue cells that escape therapy and reseed the tumor, need to be conquered for treatment to be effective. We discovered a new Achilles’ heel, the ΔNp63α-ELK3 pathway, that is required for CSCs to survive, migrate, and reseed the tumor; this project will directly test the idea that targeting this pathway offers new promise for treating HNSCC in the clinic.